Characterization of a human-specific positive regulator of flavivirus infection

Project Summary/Abstract
Flaviviruses such as yellow fever virus (YFV), Zika virus (ZIKV) or Dengue virus (DENV) are cause of great
health and economic concerns worldwide. YFV is the prototypical member of the flavivirus genus, and one of
the first human pathogenic viruses that has been identified. Despite the development of a very potent vaccine in
the 1930’s, YFV still represents a real theat. Recent outbreaks in Angola and Brazil, over the past two years,
occurred in areas with low vaccination coverage. These resurgence events have exemplified the threat and have
highlighted the need for the protection of an estimated 400 to 500 million people worldwide. Facing a significant
vaccine shortage, fractional doses of vaccine are now used during vaccination campaigns despite no/limited
evidence of long-term protection, hence underscoring the urgent necessity of developing novel strategies to
clinically manage future YFV outbreaks. Our knowledge of the YFV infectious cycle in vitro and in vivo is
extremely limited which has ultimately hampered the development of specific therapies to treat YFV infection, as
none is currently available. I recently identified a novel host regulator of YFV infection in human cells that is
required for effective YFV infection and replication in vitro. As it is not expressed in mice, this factor could also
contribute to the human/primate-specific tropism of YFV. Building on a robust set of preliminary data, I
hypothesize that this factor regulates RNA replication or protein translation through direct binding to viral
elements. In Aim 1, I will explore the mechanisms by which this factor regulates the replication of the YFV
vaccine strain YFV-17D in vitro as well as the host and virus determinants that govern such regulation. In Aim
2, I will determine the role of this factor on the replication of a virulent YFV strain, YFV-Asibi, as well as of other
flaviviruses of interest such as ZIKV and DENV. I will also seek to explore the role of this factor using more
relevant cell culture system such as primary human hepatocytes by using specific inhibitor of this factor. In Aim
3, I will use a humanized mouse model I recently developed and that is permissive to YFV infection to evaluate
the role of this factor on YFV-Asibi and YFV-17D replication in vivo, by treating mice with specific inhibitor of the
identified host factor. Altogether, my strong expertise in studying YFV virus in vitro and in vivo, combined with
the different viral tracking tools and in vivo models I have previously developed, position me very well to conduct
the proposed research. This research could provide novel avenues for the specific treatment of YFV infection
and enhance our understanding of the host-pathogen interactions that define flavivirus pathogenicity. This K22
Career Transition Award will help me achieve my scientific and career goals, which consist of transitioning toward
an independent assistant professor position and establishing an independent NIH-funded research program
aiming at elucidating the mechanisms of flavivirus pathogenicity.

Public health relevance
Project narrative Transmitted by mosquitoes, yellow fever virus (YFV) is the infectious agent causing yellow fever (YF), a disease that is lethal in 25 to 50% of the case in humans. Despite the availability of a potent vaccine, vaccine shortage and virus emergence in areas with low vaccination coverage place at risk 400 to 500 million people worldwide, hence highlighting the need of specific treatments against YF. In this proposal, I aim to characterize an interaction between YFV and the human cell that promote viral replication, which holds promise to aid the development of specific therapeutics to treat YFV infection.